ADPKD Image Repository Core

ADPKD IMAGE REPOSITORY CORE
Project Summary: Clinical and experimental models of autosomal dominant polycystic kidney
disease (ADPKD) employ imaging biomarkers (e.g., total kidney volume [TKV]) to assess prognosis,
determine clinical trial eligibility, and treatment response monitoring. However, existing TKV
measurement methods have poor reproducibility, reducing statistical power and increasing required
sample sizes and trial durations. Moreover, current risk-stratification models (e.g., Mayo Clinic
Imaging Classification [MIC], PRO-PKD, the ADPKD Outcomes Model) are limited in accurately
predicting ADPKD disease progression. We have developed automated, machine-learning-based
image processing methods that enhance the accuracy and efficiency of total kidney volume
measurement as well as assessment of other ADPKD risk factors like visceral adiposity, cyst fraction,
and hemorrhagic renal cysts. As ADPKD is a systemic condition, our PKD phenotyping also assesses
the effects of APDKD on liver, spleen, pancreas, heart (if within field of view), seminal vesicles, and
prostate gland; and enables quantitation of cysts and cyst volumes, extrarenal fluids (pleural effusion,
free pelvic fluid), fat (subcutaneous, peritoneal, peri-renal, cardiac) and muscles. Moreover, dynamic
serial MRI measurements of bladder volume increasing from one sequence to the next provide a spot
assessment of urine output. Stomach segmentations can evaluate gastric confinement. This focus on
extrarenal complications of ADPKD also has the potential to correct errors in several biomarkers
routinely used to assess health, including body mass index (which can be confounded by weight of
cyst fluid), muscle mass (potentially improving creatinine-based calculations of eGFR) and identifying
sarcopenia. Furthermore, serial MRIs analyzed by our technique predict TKV trajectory more
accurately than MIC. Our comprehensive PKD Image Phenotyping toolkit will be extended in this
proposal to pediatric subjects from the PKD-RRC and adults with early disease including test-retest
validation of all imaging biomarkers in early disease. All images entered into the Core database will
undergo rigorous quality control. The difficulty of obtaining accurate PKD image phenotyping
manually is well known among imaging specialists. It requires meticulous, detailed work by expert
observers that is time-consuming, expensive, and impractical. Our automated PKD Image
Phenotyping resource will be shared gratis with new and established investigators in collaboration
with the Administrative Core and the PKD Central Coordinating Site (CCS). We anticipate advances
in the understanding of ADPKD in patients, as well as accelerated development and testing of
candidate therapies becoming possible by providing PKD scientists and clinicians with easily
accessible, accurate, comprehensive, and reproducible PKD Image phenotyping.